Cell survival in engineered skeletal muscle: The role of complement

Abstract
Muscle loss due to trauma, tumor resection or congenital malformation is devastating to the patient and their
family. Current treatment regimens involve creative rearrangement of skin and muscle flaps to mitigate the
deformity. However, these approaches are often sub-optimal as a percentage of mobilized flap tissues contract,
atrophy and/or die and do not function like the original tissues. The field has long envisioned a treatment modality
where using the patient's own cells to create tissue grafts, that can then be transplanted into a patient to restore
form and function. However, unfortunately, there are numerous hurdles yet to be overcome for this new treatment
plan to be broadly adopted in the clinic. One urgent and underappreciated hurdle is the poor survival rate of
implanted cells which we hypothesize are killed by the innate immune response to the implanted graft. A major
effector mechanism of innate immunity is the complement (Cp) system. The extent that early Cp inflammatory
events kill a substantial number of cells within the TECs remains an important unanswered question in the tissue-
engineering field. Even if cell death due to early inflammation can be avoided, there is insufficient vascular
support. Techniques to generate pre-vascularized TECs which have rapid anastomotic potential would
substantially improve cell survival and engraftment. These two highlighted events are intimately linked.
Reduction of early inflammation without early vascular support or early vascular support in the presence of a
substantial inflammatory response will still result in cell death and failed repair. Therefore, our central hypothesis
is that; modulation of Cp effector pathways will promote survival of TEC by reducing inflammation, direct
cell injury, and by promoting neovascularity. In this proposal we articulate a line of investigation that will
lead to an enabling technology to improve the engraftment of cellularized implants by modulating the early
inflammatory process and promoting nascent microvascular beds. Our lab has invented novel strategies and
therapeutics that target the early inflammatory response. Additionally, we have recently developed a novel
scaffold-free technology to generate Self-organizing Pre-vascularized Endothelial-fibroblast Constructs
(SPECs). These engineered constructs can become perfused with blood very quickly once implanted. Using
known mechanisms of inflammation, angiogenesis and anastomosis as our guide, we will systematically test
these innovative technologies using specific inhibitors and genetically engineered mice in a sub-muscular implant
model. The expected outcomes would significantly move the field forward by providing a workable solution
to the principal hurdles facing tissue engineering - rapid vascularization and survival of implanted cells
and tissues.

Public health relevance
Project Narrative Tissue engineered constructs (TECs) have the potential to replace and/or regenerate damaged tissues and organs. However, the poor cell survival observed in TECs is a significant barrier for tissue engineering technology. Modulation of early inflammatory events driven by the complement system will promote survival of TEC by reducing inflammation, direct cell injury, and by promoting neovascularity.